Effect of blood donor sex and inter-individual variability in plasma testosterone on the transfusion effectiveness and hemostatic potential of red blood cells and platelets

PROJECT SUMMARY / ABSTRACT
The long-term goal of this proposal is to advance transfusion effectiveness and safety by addressing the gaps
in knowledge of testosterone-mediated cellular changes that impact red blood cell (RBC) and platelet function in
storage and after transfusion. We hypothesize that disruption of physiological testosterone signaling induced by
genetic, idiopathic or therapeutic intervention (testosterone replacement therapy, TRT) contributes to inter-donor
heterogeneity in the quality of blood components, and to altered transfusion effectiveness. The scientific premise
is based on our findings that supraphysiological concertation (>890 ng/dL; common in TRT) of free (bioavailable)
testosterone in plasma is correlated with increased oxidative hemolysis and decreased membrane deformability.
Relevant to transfusion effectiveness, gamma-irradiated RBC units from TRT donors had lower survival shortly
after infusion into immunodeficient mice compared with non-TRT controls, and patients’ hemoglobin increments
following a single RBC unit transfusion were reduced for RBC units from TRT donors compared to those from
non-TRT male donors (75% of non-TRT). Our studies in platelets suggested that exogenous testosterone has a
priming effect on platelets evidenced by increased aggregation and mitochondrial bioenergetics, and that TRT
was associated with increased expression of platelet activation markers in storage. In Aim 1, we will quantify the
concentrations of free and total testosterone in plasma from male donors from NHLBI’s REDS-III RBC-Omics
study with complete genotyped information and linked data of recipient outcomes after RBC transfusion events.
By measuring plasma testosterone concentration, we will be able to determine the prevalence of sub-
physiological (hypogonadism) and supraphysiological testosterone among male donors; conduct genome-wide
association (GWA) studies to identify single nucleotide polymorphism (SNP) associated with donor plasma
testosterone concentration; and define the impact of testosterone concentration and identified SNPs on
transfusion effectiveness (measured by changes in patient’s hemoglobin and bilirubin increments) using the
REDS-III vein-to-vein database. In Aim 2, we evaluate the impact of hypogonadism and TRT on platelet
phenotype and hemostatic function in therapy, in storage, and in a mouse model of transfusion. The goal is to
evaluate the feasibility of expanding the utilization of blood components derived from individuals on TRT. We
anticipate that this project’s outcomes will allow us to: identify genetic determinants of plasma testosterone that
impact the effectiveness of testosterone therapy in patients, and RBC/platelet survival in storage and after
transfusion; benefit the emerging field of precision transfusion medicine by establishing blood donor testosterone
threshold values for transfusion effectiveness and safety in vulnerable patient populations (neonates/androgen
sensitive); improve TRT donor screening to minimize recipient exposure to supraphysiological free testosterone;
reexamine current policies that limit or ban platelet donation by TRT donors; and explore differential utilization
based on TRT platelet characteristics in clinical scenarios of acute bleeding like trauma and surgery.

Public health relevance
PROJECT NARRATIVE This project evaluates the impact of blood donor variability in plasma testosterone and testosterone replacement therapy on the safety and transfusion effectiveness of red blood cells and platelets. The long-term goal is to personalize transfusion medicine by controlling biological parameters relevant to patient’s outcomes.